Randomized trial of vitamin D and omega-3 fatty acids for diabetic kidney disease

DESCRIPTION (provided by applicant): We propose a randomized, placebo-controlled clinical trial of vitamin D3 (cholecalciferol) and omega-3 fatty acids (eicosapentaenoic acid plus docosahexaenoic acid) to prevent the development and progression of diabetic kidney disease (DKD). Persons with diabetes are at high risk of developing kidney disease, and DKD is both the leading cause of end stage renal disease in the developed world and a potent amplifier of cardiovascular disease risk. Vitamin D and omega-3 fatty acids are promising interventions for DKD prevention and treatment, based on results of animal-experimental models and early human studies. Because these interventions are relatively safe, inexpensive, and widely available, they may offer opportunity to substantially reduce the burden of DKD in large populations. We aim to test whether vitamin D3 and/or omega-3 fatty acids prevent progression of albuminuria and loss of glomerular filtration rate, two complementary manifestations of DKD, over 4 years of treatment. To effectively and efficiently test study hypotheses, we propose an ancillary study to the Vitamin D and Omega-3 Trial (VITAL), an NIH-funded randomized clinical trial. In VITAL, 20,000 participants (men ages e 60 years, women ages e 65 years) will be randomly assigned in a 2x2 factorial design to vitamin D3 (cholecalciferol) 1600 IU daily versus placebo, and to eicosapentaenoic acid 500 mg plus docosahexaenoic acid 500 mg daily versus placebo, and followed for a mean of 5 years to assess effects on cardiovascular disease and cancer events. Leveraging the established infrastructure of VITAL, we propose to identify and recruit a sub-cohort of 1,500 VITAL participants with diabetes at baseline and to ascertain effects of study interventions on albuminuria and glomerular filtration rate in this group. Following the simple and cost-efficient design of the parent VITAL trial, biospecimens will be collected locally and delivered to the VITAL central laboratory by mail. First morning voids will be collected at baseline and year 4 for measurement of urine albumin-creatinine ratio. Blood samples will be collected simultaneously for measurement of glomerular filtration rate (using serum creatinine and cystatin C), 25- hydroxyvitamin D, eicosapentaenoic acid plus docosahexaenoic acid, C-reactive protein, and hemoglobin A1c. The proposed studies are designed to determine whether vitamin D3 and/or omega-3 fatty acids have causal and clinically relevant effects on the development and progression of DKD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Diabetic kidney disease (DKD) is a cause of substantial morbidity and mortality. Despite widespread use of intensive glycemic control and renin-angiotensin-aldosterone system inhibitors, renal and cardiovascular consequences of DKD remain common. This study will evaluate whether vitamin D3 and/or omega-3 fatty acids are safe and effective interventions to reduce the burden of DKD among the large and growing diabetic population. NARRATIVE Diabetic kidney disease (DKD) is a cause of substantial morbidity and mortality. Despite widespread use of intensive glycemic control and renin-angiotensin-aldosterone system inhibitors, renal and cardiovascular consequences of DKD remain common. This study will evaluate whether vitamin D3 and/or omega-3 fatty acids are safe and effective interventions to reduce the burden of DKD among the large and growing diabetic population. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Diabetic kidney disease (DKD) is a common and morbid complication of diabetes mellitus. DKD, which is characterized by progressive albuminuria and loss of glomerular filtration rate (GFR), affects up to 40% of the burgeoning diabetes population and is the leading cause of end stage renal disease in the United States, accounting for 49,224 incident cases (44%) in 2006 alone. Moreover, DKD potently amplifies the risks of cardiovascular disease and premature death by increasing the prevalence and severity of both established and novel cardiovascular risk factors. Specifically, higher levels of albuminuria and lower levels of GFR are strongly, independently, and additively associated with increased risks of cardiovascular events and mortality. The public health impact of DKD is intensified by the continually rising prevalence of diabetes. This impact is further magnified in the aging population, because diabetes and kidney disease are highly prevalent among older adults and kidney disease is among the strongest risk factors for mortality in this group. Therefore, preventing the development and progression of DKD is a critical goal for improving long-term health outcomes of the growing diabetes population and for reducing the overall burden of kidney disease in the United States. Currently available therapies do not meet the clinical need for DKD prevention and treatment. Intensive glycemic control helps to prevent albuminuria, and antagonists of the renin-angiotensin-aldosterone system (RAAS) reduce albuminuria, GFR loss, and mortality. Even with the application of these therapies, however, rates of the adverse renal and cardiovascular consequences of DKD remain unacceptably high. Thus, there is an urgent need for additional, complementary interventions to prevent and treat DKD. Vitamin D and omega-3 fatty acids are two of the most promising interventions for DKD prevention and treatment. Vitamin D suppresses the RAAS; reduces renal inflammation and glomerulosclerosis; lowers albuminuria; and prevents impairment of GFR in animal-experimental models. Importantly, these effects appear to be synergistic with RAAS blockade. Our preliminary data suggest that treatment with cholecalciferol (vitamin D3) reduces albuminuria and renal inflammation among persons with diabetes. Omega-3 fatty acids (ω-3 FA) reduce oxidative stress, endothelial activation, and inflammation and prevent albuminuria in animal- experimental models. To date, careful evaluation of ω-3 FA in DKD has been limited to small randomized trials. Nevertheless, meta-analysis of these trials suggests that ω-3 FA reduce albuminuria and possibly GFR loss. Because cholecalciferol and ω-3 FA are relatively safe, inexpensive, and widely available, they may offer opportunity to substantially reduce the burden of DKD in large populations. Prior to widespread implementation, however, these hypothesized benefits should be rigorously tested in well-powered clinical trials. Therefore, among older adults with diabetes, we aim: SPECIFIC AIM 1: To test whether cholecalciferol (vitamin D3, 1600 IU per day) prevents the development and progression of DKD, compared with placebo. Hypothesis 1a: Cholecalciferol slows progression of albuminuria over 4 years of therapy. Hypothesis 1b: Cholecalciferol reduces loss of GFR over 4 years of therapy. Hypothesis 1c: Beneficial effects of cholecalciferol are strongest among persons who at baseline have low plasma 25-hydroxyvitamin D concentration, albuminuria, and/or impaired GFR. SPECIFIC AIM 2: To test whether marine omega-3 fatty acids (ω-3 FA, eicosapentaenoic acid plus docosahexaenoic acid, 1g per day) prevent the development and progression of DKD, compared with placebo. Hypothesis 2a: ω-3 FA acids slow progression of albuminuria over 4 years of therapy. Hypothesis 2b: ω-3 FA reduce loss of GFR over 4 years of therapy. Hypothesis 2c: Beneficial effects of ω-3 FA are strongest among persons with low baseline levels of plasma eicosapentaenoic acid and docosahexaenoic acid and/or high baseline levels of C-reactive protein. To test these hypotheses effectively and efficiently, we propose an ancillary study to the Vitamin D and Omega-3 Trial (VITAL). The parent VITAL trial will be a randomized, double-blind, placebo-controlled trial of the benefits and risks of cholecalciferol and ω-3 FA in the primary prevention of cardiovascular disease and cancer. Funded by the NIH (R01 CA138962), 20,000 participants (men ages e 60 years, women ages e 65 years) will be randomly assigned in a 2x2 factorial design to cholecalciferol 1600 IU daily versus placebo, and to eicosapentaenoic acid plus docosahexaenoic acid 1 gram daily versus placebo. Planned mean follow- up is 5 years. Leveraging the established infrastructure of VITAL, we propose to ascertain effects of cholecalciferol and ω-3 FA on albuminuria and GFR among 1,500 participants with diabetes at baseline. Following the simple and cost-efficient design of the parent VITAL trial, biospecimens will be collected locally and delivered to the VITAL central laboratory by mail. First morning voids will be collected at baseline and year 4 for measurement of urine albumin-creatinine ratio. Blood samples will be collected simultaneously for measurement of GFR (using plasma creatinine and cystatin C), 25-hydroxyvitamin D, eicosapentaenoic acid plus docosahexaenoic acid, C-reactive protein, and hemoglobin A1c. VITAL presents a unique and time-limited opportunity to efficiently test our research hypotheses. In order to complete pre- randomization measurements of albuminuria and estimated GFR, it is critically important that this ancillary study be undertaken in parallel to the enrollment period for the parent VITAL trial. The placebo run-in period for the trial is scheduled to begin in April, 2010. The proposed studies are designed to determine whether cholecalciferol and ω-3 FA have causal and clinically relevant effects on the development of DKD. Strengths include the randomized, placebo-controlled study design, which minimizes the potential impact of confounding; simultaneous assessment of two promising interventions; assessment of complementary albuminuria and GFR outcomes; relatively long duration of follow- up; large sample size with adequate statistical power; and substantial cost efficiency through use of existing clinical trial infrastructure. In addition, interpretation of results will be enhanced by synergy with the funded parent VITAL trial, which includes assessment of adjudicated cardiovascular disease events, and possibly with a separate VITAL ancillary study which proposes to assess effects of VITAL interventions on diabetic retinopathy within the same 1,500-person diabetes population proposed herein (NIH application submitted June, 2009). Thus, study results can be viewed in the context of other major macro- and micro-vascular diabetes complications. Null results of the studies proposed herein would suggest that salutary effects of vitamin D and/or ω-3 FA observed in animal-experimental studies do not translate to meaningful clinical benefits in early DKD. Positive results would support wide-spread use of cholecalciferol and/or ω-3 FA interventions among the growing and high-risk population of persons with diabetes.